CSHL Imaging Structure & Function in the Nervous System

Abstract
Advances in light microscopy, digital image processing, and the development of a variety of powerful
fluorescent probes present expanding opportunities for investigating the nervous system, from synaptic spines
to networks in the brain. Addressing the need for intensive research training in this field, Cold Spring Harbor
Laboratory will offer the annual three-week course on Imaging Structure and Function in the Nervous
System, as part of its postgraduate summer training program in neurobiology (2020-2024).
This intensive laboratory and lecture course will provide participants with the theoretical and practical
knowledge to utilize emerging imaging technologies. The primary focus of the course will be on in vivo
applications of light microscopy, particularly functional imaging with genetically encoded calcium indicators.
Methods taught will include multi-photon and light-sheet microscopy, and combination of imaging with
optogenetics. Lectures by leading experts will progress through basic concepts to presentation of cutting-edge
methods. Students will learn the fundamentals of optics and microscopy, as well as the use of different types of
cameras, laser scanning systems, in vivo preparations and image processing and analysis software. A strong
emphasis is placed on building exercises that allow students to develop an understanding of basic principles,
while also introducing them to a variety of state-of-the-art commercial systems. Robust experimental design
and data collection/management strategies are integral features emphasized throughout the course.
The lead instructors are chosen on the basis of their contributions to and knowledge of the field. In turn,
they invite lecturers who have made significant contributions in their fields to give up-to-the-minute reports on
the underlying technology and their current research. The trainees are chosen by the course faculty from larger
pools of applicants and range from graduate students to senior investigators and research physicians. This
intensive research training program enrolls a diverse cadre of researchers who can immediately transfer
techniques and concepts learned during the course to their own research projects and interests, while
embedding the trainees in a collaborative network of researchers interested in using advanced light
microscopy techniques to the study of brain function and dysfunction. The faculty are encouraged to present
relevant methodological approaches in the broader context of brain function and mental health research.
Methods and concepts taught in the course are disseminated to the wider research community through the
publication of laboratory manuals and online resources.

Public health relevance
PROJECT NARRATIVE Fundamental advances in our understanding of the normal function of the human brain, and how this understanding can be used to combat brain disorders, will increasingly depend on researchers equipped with multidisciplinary technical expertise. Major advances in the use of the light microscope to probe brain function have been made in the past three decades, and the technologies continue to improve and advance at a rapid rate. This grant supports an advanced hands-on summer course focused on using light microscopy approaches in the nervous system. The course communicates cutting- edge experimental approaches and concepts to a select cadre of postgraduate trainees, who will immediately apply what they learn to their own areas of neurobiological research. This highly intensive course provides a forum for in-depth evaluation of the emerging and converging light microscopy techniques to probe human brain function and disease, and helps to embed the trainees in a collaborative network of like-minded scientists who are working to understand brain function and the etiology of mental disorders.